Team-Based Design in Biomedical Engineering Education

NIH R25 (PAR-19-215) “Team-Based Design in Biomedical Engineering
Education”
Abstract
The typical undergraduate Biomedical Engineering (BMED) curriculum includes a broad base of
coursework in math, biology, chemistry, physics, and general engineering – typically serviced by
other departments, before beginning – what students often call – their “real” BMED education in
their third year in the program. We have developed a Biomedical/Clinical Engineering
Partnership (BiCEP) program to provide clinically-relevant team-based design experiences at
every level of the curriculum. Projects and experiences seed and germinate, feeding additional
entrepreneurial opportunities beyond the core undergraduate curriculum. At the core of the
BiCEP program consists of two parts: i) Summer Immersion in Design Experience (SIDE)
course focusing on the device design and development process and entrepreneurship in the
biomedical space, and ii) a Clinical Immersion Experience (CLINEX) program that engages
students with clinical mentors in a hospital setting.
Combining these experiences for students between their 2nd and 3rd years of the program
provides a contextual bridge between their varied lower-division coursework and their more
integrative upper-division core courses in the BMED program. Observing procedures in clinical
and hospital settings, and engaging with their clinical mentors, students will develop a project
idea and carry it through needs finding, ideation/brainstorming, and prototyping phases. SIDE
coursework will scaffold their clinical experiences, providing a forum for sharing clinical
observations and aid the development of their projects.
Multiplying the impact of the SIDE, students and faculty will develop projects to integrate in to
coursework at every stage of the BMED program. Clinical observations and ideation activities in
first year introductory major courses, prototyping activities in second year design and
manufacturing coursework, modeling projects in third year simulation and analysis coursework,
and most importantly, SIDE participants and clinical mentors will act as “clients” for our
capstone senior design projects in the fourth year of the program. Successful projects at the
capstone level are further expanded into graduate level projects through our Master’s Project
Track and/or engaged with the Center for Innovation and Entrepreneurship for student-led
business creation, acceleration, and incubation.
The goal of this program is to integrate the clinical and medical context with design experiences
throughout the BMED curriculum.

Public health relevance
NIH R25 (PAR-19-215) “Team-Based Design in Biomedical Engineering Education” Narrative The proposed BiCEP program aim to integrate the clinical setting and relevant, contemporary biomedical practice in to the undergraduate curriculum and consists of two parts: i) Summer Immersion in Design Experience (SIDE) course focusing on the device design and development process and entrepreneurship in the biomedical space, and ii) a Clinical Immersion Experience (CLINEX) program that engages students with clinical mentors in a hospital setting. The goal of this is to provides a contextual bridge between students’ varied lower-division coursework and their more integrative upper-division core courses in the BMED program, ultimately leading to a more innovative and relevant educational experience. Integrating the clinical and medical context with design experiences throughout the BMED curriculum, and focusing on team-based design experiences is expected cultivate an ecosystem to support innovative projects and educate creative Biomedical Engineering professionals.